Core E: Models of Genome Instability and Aging

Genome instability, a primary hallmark of aging, is defined as DNA damage driven by exogenous genotoxin
exposure or endogenous events (genotoxins produced through normal metabolic processes, oxidation, and
hydrolysis), DNA replication errors (point mutations, insertions and deletions, base mismatches that are not
corrected), errors in chromosome segregation, and activation of transposable elements. These events can occur
anywhere in the genome including in telomeric DNA. Genotoxic stress chronically activates the DNA damage
response (DDR), which drives cell fate decisions such as cellular senescence or apoptosis, both of which lead
to attrition of functional parenchymal and stem/progenitor cells, with the former also driving chronic sterile
inflammation. Alternatively, changes to the genomic sequence may contribute to aging by driving loss of
expression of key gene products or producing transcriptional noise through epigenetic changes. Therefore, it is
valuable to the field of aging biology to rigorously determine not only the extent of DNA damage with age, but
also to evaluate other hallmarks of aging that are linked to genome instability that are more tractable to
intervention. Core E has amassed a unique and large collection of human samples and murine models (and a
tissue bank from the mice) in which there is a DNA repair defect. These models enable the analysis of the
molecular, cellular, and organismal impact of spontaneous, endogenous DNA damage. These models are also
hypersensitive to exogenous genotoxins, enabling the study of environmental or iatrogenic factors that contribute
to normal or accelerated aging. Thus, the overall goal of this Models of Genome Instability and Aging Core E
is to make these models available to the broader aging research community for careful examination of how
genome instability is linked to other hallmarks of aging that are more amenable to geroscience strategies. We
propose to provide access to primary and immortalized cells from human subjects with well-established genome
instability disorders; provide access to mice, tissues, and primary cells from mice with well-established defects
in genome maintenance including live mice for specific tissue collections or intervention studies; and generate
novel mouse models and human cells to interrogate the impact of genome instability on other hallmarks of aging.
The pre-existing resources in Core E have already supported the research of dozens of internal and external
laboratories. Overall, Core E will provide and create biospecimens that dovetail seamlessly with workflows in
the other MN NSC Research Resource Cores to measure DNA damage and repair, DDR, and epigenetic
changes. We also have the expertise to prepare samples for sc/snRNAseq and spatial proteogenomics. Thus,
this Core represents a novel resource to the field of aging biology to interrogate the mechanism behind how
genome instability, a primary hallmark of aging, drives aging and disease, and is distinct but complementary to
resources provided by existing NSCs.